Administration

Core A is the administrative core of this Program Project Grant. Core A will support the overall administration of this Program Project Grant by preparing and/or assisting in the preparation of all progress reports, by supervising finances, by keeping records of all imaging studies and study participants, by processing subject payments, by processing all MRI scan charges, by maintaining all consent forms and IRB protocols, and by tracking all archived media. Core A will also organize and support the annual visit of the External Advisory Committee.